RADx-Rad Discoveries & Data: Consortium Coordination Center Program Organization

ABSTRACT

Preparing SARS-­CoV-­2 testing data for reuse requires making the data syntactically and semantically equivalent.
Standardization of terminologies and a common data model accomplish the former, while the latter is
accomplished through understanding the data and making it comparable across RADx-­rad awardees by
benchmarking against known gold standards. The standardization of samples is as important as standardizing
the data, particularly in the highly innovative RADx-­rad program, where new technologies will be developed or
optimized for deployment in various settings. Highly motivated RADx-­rad awardees will receive advice on how
their diagnostics compare to FDA-­approved ones, with each other, how their diagnostic performs in independent
testing, as well as how to ensure the tests are usable in real world settings. In collaboration with University of
Texas Health Science Center at Houston, University of California San Diego researchers in informatics/data
science and infectious diseases with ample experience in leading large consortia have designed a unique RADx-­
rad Consortium Data and Coordination Center (radCDCC). This center is based on three pillars: (1) effective
administration and coordination among awardees, NIH, and other programs;; (2) innovative approaches and tools
to collect and standardize data and metadata to promote findability, accessibility, interoperability and reuse
(FAIR) for data sharing;; and (3) principled preparation of standardized samples with known quantities of viral
loads, and standardized procedures for testing new diagnostics to allow comparison across tests and calibration
of new technologies. Backed by sophisticated HIPAA-­compliant cloud services, user friendly web-­tools, and
extensive support from UCSD’s facilities for computation and for clinical research, the radCDCC will interface
with other RADx programs and other COVID-­19 focused programs at NIH to ensure alignment of awardees, NIH
and the public in the pursuit of effective, affordable, and deployable new technologies for testing.

Public health relevance
NARRATIVE The RADx- rad Consortium Data and Coordination Center (radCDCC) will use advanced data management to coordinate a consortium of innovative COVID- 19 diagnostic technology developers. The partnership between the University of California San Diego and the University of Texas Health Science Center at Houston brings together informatics/data scientists and infectious diseases specialists who will standardize viral samples, testing and procedures, as well as data in order to integrate and share data in a meaningful manner.